The Role of Aco2 in progressive hearing loss

PROJECT SUMMARY/ABSTRACT
Deafness is a significant health concern that affects more than 450 million people worldwide, and both
environmental insults and genetic mutations are contributing factors. The auditory organ in the inner ear is
composed of sensory hair cells that detect and transmit sound vibrations. Hair cells are innervated by bipolar
spiral ganglion neurons (SGNs) that relay auditory signals from the hair cells to the brainstem. Damage causing
SGN degeneration or affecting SGN projections or synapses with hair cells leads to hearing loss. Mitochondrial
dysfunction is a common cause of pathologies targeting organs that require large amounts of energy to perform
optimally, such as neurons. Nuclear DNA mutations in genes encoding mitochondrial proteins can affect
mitochondrial biogenesis or energy metabolism pathway, affecting auditory function in either case. A focus of this
study, variants in the mitochondrial ACO2 protein have been associated with optic nerve atrophy, seizures, and
hearing loss in young children. ACO2 is a nuclear gene that produces aconitase hydratase 2, an early enzyme
in the tricarboxylic acid cycle. Unfortunately, cellular or mechanistic insight into ACO2-related conditions is
lacking in part due to the absence of adequate animal models. We identified a spontaneous recessive R56L
amino acid substitution in the mouse Aco2 gene based on circling behavior. Homozygotes are viable but show
early-onset progressive hearing loss at 1 month of age followed by severe SGN loss at 2 months. I propose that
the ACO2 R56L protein variant results in SGN apoptosis due to mitochondrial dysfunction, explaining early-onset
hearing loss. Aim 1 of this proposal will track SGN defects in the Aco2 R56L mutants from developmental stages
to young adults. Aim 2 will investigate how the R56L mutation affects the dose and localization of the ACO2
protein, and establish how SGN mitochondria number and distribution is altered in time in mutants. Aim 3 will
attempt to rescue mitochondrial defects and loss of SGNs in mutants via metabolic supplementation. This will
first be tested in organ culture prior to exploiting these results in live mice to improve auditory function. The
proposed research has the potential to help develop realistic treatments to prevent or rescue hearing loss in
ACO2 patients. Moreover, the new Aco2 R56L mouse strain will be invaluable to model other neurological
disorders in ACO2 patients, including optic atrophy.

Public health relevance
PROJECT NARRATIVE Deafness is a major health issue affecting millions of people worldwide, and genetic mutations in mitochondrial- related genes are a significant contributing factor. The research proposed aims to characterize the role of ACO2, a mitochondrial enzyme in the energy metabolism pathway that was associated with syndromic hearing loss in infants and children. A new and first Aco2 mouse model will allow us to characterize the progression of mitochondrial dysfunction, neuronal degeneration, and deafness and to test possible therapeutic interventions.